Diabetes and Metabolism

Project Abstract
In 1988 the Mayo Clinic training programs in Endocrinology (DK07147 funded in 1968) and Diabetes and
Metabolism (DK07352 funded in 1979) were merged to create this Training Program in Diabetes and
Metabolism (DK07352). This program supports postdoctoral research training in Endocrinology, Diabetes and
Metabolism for individuals with MD, MD,Phd, or PhD degrees. Our goal is to prepare trainees for academic
careers with the ability to conduct research as independent investigators. The Program supports up to three
years of laboratory research training. The faculty consist of 20 investigators funded with NIH R01 grants and/or
other funds, 4 of whom are junior faculty members in the process of developing independent programs and
mentoring skills. We work with adjunct faculty in both basic science and clinical departments. The Program is
provides trainees with: (i) intense, in-depth education regarding all components of the scientific method, (ii) a
specific project to gain a focused approach to scientific investigation, (iii) experience with state-of-the-art
analytical tools and methodologies, (iv) grant writing abilities, and (v) the skills needed to become independent
biomedical research scientists. We provide access to formal didactic course work (including classes on grant
writing and participation in mock study sections), the opportunity to attend intra- and extra-mural seminars,
conferences and scientific presentations related to their area of study. These opportunities are in the context of
a focused research experience in the laboratories of established investigators. The Program is administered by
the Steering Committee and chaired by the Program Director, with advice from an External Advisory
Committee. The Steering Committee is responsible for interviewing and selecting trainees, as well as assuring
they have an appropriate laboratory assignment and didactic curricula. They review the trainees' initial project,
and assist with the annual review of the trainees' progress.
We are committed to maintaining a focused approach to well-defined training goals for each laboratory-based
trainee with sufficient dedicated research time to assure an optimal educational experience. Our full facutly are
very successful in obtaining extramural funding as we would expect of independent investigators that serve as
primary faculty. We believe our training record is exceptional and that it has been enhanced by our enthusiastic
and knowledgeable junior training faculty. We can also point to support from adjunct faculty whose primary
areas of basic science and/or clinical investigation are intimately tied to those of metabolism, diabetes and
endocrinology. The breadth of the faculty's research programs is notable; ranging from molecular
endocrinology to clinical research. Because our program continues to be highly sought after, because of the
success of our trainees, and because the large amount of research funds awarded to our highly qualified
faculty, we propose to continue our program at the current level of 6 fellowship slots.

Public health relevance
PROJECT NARRATIVE This application is for renewal of a Training Program in Diabetes and Metabolism that has been funded for the last 45 years. The Program provides postdoctoral research training for MD's, PhD's, or MD/PhD's in Diabetes and Metabolism for 6 individuals for a maximum of three years. Trainees will work in the laboratories of 20 investigators in preparation for academic careers as independent investigators.